Project 4- Population level language and literacy screening: An early warning system for word and language related reading disabilities (T4)

The ability to understand the development trajectory of reading disabilities is essential for early preventive
models of remediation. Reading disabilities- word level (i.e., dyslexia) reading disabilities associated with oral
language difficulties are important educational and public health concerns. Previous foundational work has
demonstrated the importance of collecting early screening data on both language and literacy skills to make
robust predictions of reading and language risk. Empirical data suggest that combining multiple variables
including known early predictors of reading achievement may improve predictive power and have better
longitudinal stability. Further, it is possible that the inclusion of contextual community factors may enhance our
understanding of early reading risk for diverse student subgroups. Specific aim 1 explores different
conceptualizations of risk, including early literacy and language predictors for diverse subgroups of children to
example early risk for SRD, and ultimate diagnosis of SLD. Specific aim 2 incorporates community level
contextual factors to the predictors of risk status in addition to the early literacy and language variables.
Specific aim 3 will utilize a mixed methods approach to determine describe and quantify educator uptake of the
screener data to make child-level instructional decisions. This project has access to population level data and
therefore will study, analyze, and report disaggregated results for historically understudied and underserved
populations (e.g., English learners, families living in poverty, racial/ethnic identity) as we work to achieve the
three specific aims.